EPIGENETIC MECHANISM OF THE SYNERGISTIC TUMORIGENIC EFFECT OF ARSENICAND BENZO[A]PYRENE CO-EXPOSURE

PROJECT SUMMARY/ABSTRACT
Arsenic and benzo[a]pyrene (BaP) are among the most common environmental pollutants and human exposure to
arsenic and BaP mixture is very common. Our knowledge on the effect and mechanism of arsenic and BaP co-
exposure is limited. The goal of this study is to determine the mechanism of the effect of arsenic and BaP co-
exposure. Epigenetics refers to heritable changes in the pattern of gene expression that are not caused by changes
in DNA sequence, but are mediated by DNA methylation, histone posttranslational modifications and noncoding
RNAs. Cancer stem cells (CSCs) are cancer cells possessing characteristics of normal stem cells. CSCs or CSC-
like cells are considered as cancer initiating cells. While the mechanism of arsenic toxic effect is not clearly defined,
it is thought that the toxic effect of BaP mainly depends on its metabolic activation and DNA adduct formation. The
reported effects of arsenic on DNA adduct level are controversial, suggesting that other mechanisms may play a
key role in the combined effect of arsenic and BaP co-exposure. Our preliminary studies found: (i) Arsenic and BaP
co-exposure has a synergistic effect in inducing cell transformation, CSC-like property and lung tumors; (ii) Arsenic
and BaP co-exposure has no synergistic effect on BPDE-DNA adduct level. In contrast, the co-exposure shows a
synergistic effect in epigenetic deregulations as evidenced by increasing the levels of histone H3K9
methyltransferase SUV39H1 and H3 repressive methylation mark H3K9me2. Moreover, the co-exposure also
shows a synergistic effect in reducing the level of suppressor of cytokine signaling 3 (SOCS3) and increasing Akt
and Erk1/2 activation; (iii) ShRNA knockdown SUV39H1 reduces H3K9me2 level, increases SOCS3 level, reduces
Akt and Erk1/2 activation and soft agar colony formation and CSC-like property; (iv) Stably re-expressing SOCS3
reduces Akt, Erk1/2 activation, soft agar colony formation and CSC-like property; (v) Inhibiting Akt and Erk/1/2
reduces soft agar colony formation and CSC-like property; and (vi) Arsenic and BaP co-exposure significantly
increases aryl hydrocarbon receptor (AhR) nuclear localization and siRNA knockdown AhR greatly reduces the
level of SUV39H1 in arsenic and BaP co-exposure-transformed cells. Based on our preliminary data, our central
hypothesis is: (i) Arsenic and BaP co-exposure up-regulates HMTase SUV39H1 via synergistically activating AhR;
(ii) Up-regulation of SUV39H1 leads to SOCS3 down-regulation; and (iii) Down-regulation of SOCS3 causes a
stronger Akt and Erk1/2 activation, which enhances cell transformation and CSC-like property thus increasing lung
tumorigenesis. Three aims are proposed: Aim 1: Arsenic and BaP co-exposure significantly enhances cell
transformation and tumorigenesis by up-regulating HMTase SUV39H1 via synergistically activating AhR. Aim
2: SUV39H1 up-regulation by arsenic and BaP co-exposure enhances cell transformation and tumorigenesis
by down-regulating SOCS3 leading to stronger activation of Akt and Erk1/2. Aim 3: Simultaneously inactivating
both Akt and Erk1/2 by a natural compound Withaferin A impairs the synergistic effect of arsenic and BaP co-
exposure in inducing cell transformation and lung tumorigenesis in mice.

Public health relevance
PROJECT NARRATIVE Arsenic and benzo[a]pyrene (BaP) are among the most common environmental pollutants and human exposure to arsenic and BaP mixture is very common representing a major environmental health concern. The long term goal of this study is to determine the mechanism of toxic effect of arsenic and BaP co-exposure and identify molecular targets for better treatment and prevention of diseases resulting from arsenic and BaP co-exposure.